Hematopoietic stem cell defects in Diamond-Blackfan Anemia

PROJECT SUMMARY
Diamond-Blackfan anemia (DBA) is a rare inherited bone marrow failure disorder caused mainly by heterozygous
loss-of-function mutations in 20 out of 83 ribosomal protein (RP) genes, the most commonly affected one being
RPS19. DBA usually presents with erythroid production failure during infancy, although clinical observations
suggest impaired hematopoietic stem cell (HSC) function in some older DBA patients. Characterization of this
suspected HSC defect is limited by difficulties in obtaining DBA patient CD34+ hematopoietic stem and progenitor
cells (HSPCs) and the lack of ideal human cellular experimental models. I have used Cas9 to create RPS19
haploinsufficiency in healthy donor CD34+ HSPCs. My preliminary data show that RPS19+/- HSPCs exhibit
impaired erythropoiesis and normal myelopoiesis in vitro and impaired bone marrow repopulation ability following
xenotransplantation into immunodeficient mice, suggesting an HSC defect. Co-disruption of TP53 completely
rescues the erythroid defect and partly alleviates the HSC defect. Furthermore, transcriptome analysis shows
increased expression of PRC2 target genes in RPS19+/- HSPCs. This indicates reduced PRC2 activity, which
epigenetically represses a gene program that is essential for HSC maintenance. Accordingly, my K99/R00
proposal investigates the hypothesis that RPS19 haploinsufficiency impairs HSPCs by inducing TP53 activity
and reducing PRC2 activity. I will test this hypothesis by defining the effect of RPS19 haploinsufficiency on the
lineage developmental potential of defined HSPC subpopulations (Aim 1) and describing the molecular
mechanisms underlying activation of TP53 and reduction of PRC2 activities in RPS19+/- HSPCs (Aim 2). Lastly,
I will utilize cutting-edge approaches, including single-cell studies, to describe alterations in transcriptome and
translatome networks in RPS19+/- HSPCs (Aim 3). These investigations will elucidate a poorly understood aspect
of DBA pathophysiology and provide new insights into the biology of HSCs. I will carry out the K99 phase of
these aims in an exceptional research environment under the guidance of a senior mentorship team and a formal
plan to receive training in advanced laboratory methods and various aspects of career development. My
research, training plans and transition to independence achieved under the auspices of the K99/R00 mechanism
will support my long-term goal of becoming an independent, NIH R01-funded physician-scientist with expertise
in ribosomal biology, human hematopoiesis, bone marrow failure syndromes, bone marrow transplantation and
gene therapy.

Public health relevance
PROJECT NARRATIVE I have used CRISPR/Cas9 technology to create a new human cell-based experimental model for Diamond– Blackfan anemia (DBA), a rare but devastating blood disease that causes isolated anemia in children and global suppression of blood formation in many older patients. Using my new approach, I showed that the mutations in RPS19, the most commonly affected gene in DBA, impair the function of blood-repopulating hematopoietic stem cells (HSCs). My planned project to study this impairment should lead to improved understanding of DBA, identify new therapeutic strategies, and elucidate a new facet of ribosomal and HSC biology.